INVESTIGATION OF UVAR PHOTOPHERESIS SYSTEM IN CONJUNCTION WITH UVADEX

This is an unblinded study of the effectiveness of UVAR photopheresis in conjunction with UVADEX for refractory heart transplant rejection. Clinical data will be collected at baseline, 2 weeks and monthly for four months thereafter. Analysis comprises comparison of frequency of rejection before, during and after treatment.